AMBISOME VS AMPHOTERICIN B FOLLOWED BY FLUC FOR CRYPTOCOCCAL MENINGITIS IN AIDS

This study is designed to compare two doses of AmBisome anf amphotericin B, and observe for safety and efficacy in AIDS patients with first episode crytoccal menigitis.